Language as a Candidate Marker of FXTAS in FMR1 Premutation Carriers

Project Abstract
The FMR1 premutation (PM) affects ~1 in 150 women and ~1 in 470 men in the United States, and can have a
significant effect on physical and mental health. Forty percent of male PM carriers develop fragile X-associated
tremor/ataxia syndrome (FXTAS) after the age of 50, though precisely who will manifest the disease is unknown.
FXTAS is characterized by executive dysfunction, gait ataxia, and intention tremor, and it is possible that
cognitive changes may affect other phenotypes, such as language. In the absence of clear markers of disease
onset among male PM carriers, it is essential to characterize language in this population, which has proven to
be a successful approach in related neurodegenerative disorders (e.g., Alzheimer’s). Numerous studies have
demonstrated that female PM carriers differ from controls in their language (i.e., pragmatics, lexical-semantics),
which has been associated with poorer executive function and reduced quality of life; however, no studies to
date have examined language among male PM carriers. As a first step, the present proposal will examine
language among male PM carriers across the FXTAS symptom continuum (i.e., no symptoms through severe
symptoms). Without such data, this severely limits our ability to (a) fully understand the impact of the FMR1 PM,
(b) examine cognitive correlates implicated in FXTAS (i.e., executive dysfunction), and (c) understand the
implications of language use on quality of life. This proposal addresses these limitations with three aims: i)
Examine associations between age, FXTAS-associated symptoms and pragmatic and lexical-semantic aspects
of language among male PM carriers across contexts; ii) evaluate relationships with executive functioning; iii)
assess interactions between language, age, and quality of life. This study will be completed virtually with a cross-
sectional sample of 60 male PM carriers between the ages of 45-70 across the FXTAS symptom continuum.
Males from across the U.S. will be recruited. Participants will complete virtual language elicitation and executive
function tasks, as well as self-report measures of executive function and quality of life. Results from this proposal
are expected to inform the relationship between language, age, and FXTAS-associated symptoms among male
PM carriers. It is also expected that age-related executive dysfunction will adversely influence pragmatic and
lexical-semantic language. Finally, we anticipate that reduced quality of life among older male PM carriers will
adversely affect language. This proposal is consistent with the mission of the National Institutes of Health to
enhance health and reduce disability by expanding our understanding of a neurodegenerative condition
associated with a common genetic variant, the FMR1 PM. It also contributes to the strategic mission of the
National Institute on Deafness and Other Communication Disorders by informing knowledge on the basis of
language impairments among individuals with neurodegenerative disorders and links with quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will contribute to our understanding of the basis of language impairments among individuals with neurodegenerative disorders, as well as links between language and quality of life. This study will examine language production in a cross-sectional sample of adult males with the FMR1 premutation and in relation to a key cognitive domain among premutation carriers - executive functions. Given the prevalence of the FMR1 premutation among males (1 in ~470), this work has the potential to expand our understanding of candidate language markers associated with a fragile X-associated neurodegenerative condition (FXTAS) and the phenotypic scope of the FMR1 premutation, thus informing links between genetics and language.